PAC1 receptor antagonists as potential treatments for depression and atherosclerosis associated with chronic stress

During this period, compounds identified by screening compounds from HTS library and others identified by molecular modeling and virtual screening studies were examined for their capacity to antagonize PAC1R. Additionally, compounds that have recently been reported in the literature were assessed for their capacity to antagonize the receptor. The team summarized findings in a manuscript. Additional high-throughput screening utilizing molecular modeling approaches in conjunction with a neuroblastoma reporter cell line is being considered.